Addressing Health Equity in Tobacco Cessation Treatment for Historically Underrepresented Veterans

Background: Tobacco inflicts a tremendous health burden on its users. Veterans use tobacco products at a
higher rate than seen in the US adult population. Nearly 16% of African American Veterans and 11% of
Hispanic Veterans smoke, compared to 12% of White Veterans. Risk of developing tobacco-related disease is
highest for African American Veterans, with higher use of menthol cigarettes than other Veterans increasing
burden. Hispanic Veterans are also at elevated risk for developing tobacco-related disease. However, both
African American and Hispanic Veterans’ use of evidence-based tobacco cessation treatment in the Veterans
Health Administration (VHA) is low, despite the 2019 VHA Directive 1056 updated requirements for increasing
access to evidence-based tobacco cessation to Veterans. African American and Hispanic Veterans who use
tobacco report greater readiness to quit and are more motivated to quit than White Veterans. High levels of
motivation, desire to quit, and acceptability of treatment options should result in high levels of treatment
initiation. However, low initiation of treatment may reflect cultural barriers to treatment and the need for tailored
strategies to increase use.
Significance/Impact: The project aims to improve the health of African American and Hispanic Veterans by
addressing health equity and evaluating social determinants of health associated with accessing tobacco
cessation treatment use, combining two important HSR&D research priorities. Increasing the proportion of
African American and Hispanic Veterans that use tobacco cessation treatment in the VHA would greatly
diminish disease burden, prevent mortality, and increase functioning in this underserved population. That, in
turn, would decrease the healthcare burden on VHA, as well as the $2.7 billion dollars spent annually on
tobacco-related care. Lastly, the project aligns with ORD-wide research priorities to expand historically
underrepresented Veterans’ access to quality clinical trials and promotion of equity.
Innovation: Project innovations include: 1) focusing on vulnerable and underrepresented African American
Veteran and Hispanic population, 2) addressing under-researched health equity in tobacco cessation treatment
in VHA, 3) novel use of the population-specific, health communication research methods, and 4) obtaining
input from both Veterans and national stakeholders.
Specific Aims: The project has 3 aims. Aim 1: Identify barriers and facilitators impacting delivery of tobacco
cessation treatment to African American and Hispanic Veterans across facilities within VISN 16. Aim 2:
Develop the Engagement, Navigation, and Transmission Intervention for Cessation Efficiency (ENTICE)
intervention to increase African American and Hispanic Veteran initiation of tobacco cessation treatment. Aim
3: Conduct a pilot trial of ENTICE for African American and Hispanic Veterans at the Houston VAMC.
Methodology: For Aim 1, a mixed-methods evaluation (interviews and VA administrative data) will identify
barriers and facilitators of delivery of tobacco cessation treatment to African American and Hispanic Veterans
across VISN 16. For Aim 2, the Boot Camp Translation process will integrate patient recommendations to
develop two population-specific ENTICE interventions with 8 African American and 8 Hispanic Veterans who
use tobacco and 4 African American and 4 Hispanic community members during a full-day retreat followed by
3, 1–3-hour sessions. For Aim 3, a pilot randomized controlled trial will assess the feasibility and acceptability
of ENTICE compared to Enhanced Usual Care for 32 African American and Hispanic Veterans tobacco users.
Next Steps/Implementation: Strategies and information generated during this project will highlight potential
gaps in care that affect African American and Hispanic Veteran health and overall strength of the VHA system
by addressing under-researched gaps in health equity. Activities in this project will foster the PI’s growth as an
independent VA researcher and allow execution of a line of research that advances health equity in VHA.

Public health relevance
African American and Hispanic Veterans use tobacco cessation treatment at lower rates than other White Veterans, despite greater tobacco use burden. Proactive outreach attempts to address barriers in initiating tobacco cessation treatment among African American and Hispanic Veterans is important. Development and implementation of health communication interventions that address barriers at multiple health care system levels that impede use of tobacco cessation treatment have been effective in increasing use among Veterans. However, few attempts have been made to develop health communication interventions specific for African American and Hispanic Veterans. Additionally, little is known about the barriers and facilitators in delivery of tobacco cessation treatment that impact African American and Hispanic Veterans, specifically. The goal of this CDA is to collaborate with Veterans, VA personnel, and stakeholders to improve initiation of tobacco cessation treatment for African American and Hispanic Veterans, while examining factors that impact their use treatment.